Representation and computation of semantic categories in the dorsal visual stream

PROJECT SUMMARY
Humans and other primates display tremendous visual intelligence, effortlessly rendering information from an
extremely high-bandwidth input modality in a format that is understandable and generally useful for behavior.
This occurs through at least two forms of discretization: we identify discrete objects and group them into
discrete categories. Such categories are closely related to abstract symbols, neuronal representations of which
have been proposed to enable us to form new concepts from familiar ones. This ability is critical for intelligent
behavior, highlighting the importance of understanding the symbolic representations that enable it.
While neuronal representations in the late stages of the primate ventral visual stream capture
information about ‘natural’ categories (e.g. shapes, colors, or object types, like cars vs. faces) through a
property called ‘disentanglement’, the neural basis for decomposition into semantic categories, which are
defined through experience, remains unknown. In this project I address this gap through analysis and modeling
of a first-of-its-kind neurophysiology dataset collected across the dorsal visual stream in many macaque
monkeys trained to categorize visual motion by its direction. Through a combination of (a) modern population-
level analysis of these data leveraging the emerging toolkit of representational geometry, and (b) artificial
neural network modeling, this project will address how the primate brain solves the problem of generating
representations that reflect semantic categories.
Central hypotheses: Representations that capture semantic categories based on motion are generated
through hierarchically through the dorsal visual stream through a series of transformations that progressively
distort sensory feature representations to emphasize their learned behavioral meaning (category) (H1). This
enables the behavioral benefits of categorization (interpolation to new stimuli within the same category, more
reliable responses) without compromising behaviors depending on veridical representation of stimulus features
(H2).
Aim 1: I will compare population codes for visual motion direction across representational stages MT-MST-LIP
using large-scale macaque neurophysiology data.
Aim 2: I will identify computations underlying category-aligned representational changes between stages of the
dorsal visual stream using neurophysiology data and artificial neural networks (ANNs).
Aim 3: I will model the behavioral implications of semantic category-aligned representations using multi-layer
ANNs to understand the computational tradeoffs imposed by explicit category representation.

Public health relevance
PROJECT NARRATIVE Humans and other primates understand and interact with the visual world by breaking it into parts: we detect discrete objects and group them into discrete categories in myriad ways. In this project we use a novel large- scale neurophysiology dataset, state-of-the-art neuronal population analyses, and artificial neural network modelling to study how the brain assembles representations of experience-dependent ‘semantic’ categories through successive stages of the dorsal visual stream. Understanding the format and function of semantic category representations in the brain will shed light more broadly on how neural systems may generate symbolic representations, which is thought to enable our ability to generalize our knowledge and reason intelligently.